Career Enhancement Core

Project Summary:
The CEC Core of the Colorado SCORE program is focused on providing career enhancement
for researchers in the innovative, growing field of sex differences research. The Objectives of
the CEC Core are 1) To develop and support a cadre of accomplished early career researchers
in the thematic focus of the SCORE, Bioenergetic and Cardiometabolic Consequences of the
Loss of Gonadal Function, and 2) To provide a curriculum that meets the career enhancement
needs of the early career faculty scientists focused on translational science in the study of sex
differences. Objective 1 will be carried out by selecting a SCORE Scholar through peer review
who will be focused on developing a career in sex differences research. The SCORE Scholar
will have salary support to cover at least 75% of their time as well as project support. In addition,
relevant pilot projects will be awarded (by peer review) to four promising scientists per year. For
Objective 2, SCORE Scholars and Pilot Awardees will participate in an innovative career
enhancement program including team mentoring, hands-on research experience and
curricular training in academic skills, career development skills and methods by which to study
sex differences from the Ludeman Family Center for Women’s Health Research (Ludeman
Center) as well as a weekly works in progress session run by the Investigations in Metabolism,
Aging, Gender, and Exercise (IMAGE) group of the Multidisciplinary Center on Aging (home of
the SCORE). In addition, trainees will receive training in relevant topics in endocrinology.
SCORE Scholars and Pilot Awardees will receive curricular training along with the Scholars in
the Building Interdisciplinary Research Careers in Women’s Health (BIRCWH) K12, Colorado
Clinical & Translational Sciences Institute (CCTSI) and the Ludeman Center. These trainings
will be provided by the Ludeman Center. Dr. Regensteiner, proposed CORE Leader, is the
Director of the Ludeman Center as well as PI of the BIRCWH grant and has led the
development of the academic skills and career development skills curricula that will be utilized in
the proposed SCORE. The mentoring, research experience and curricular training provided by
this program will help the SCORE Scholar and Pilot Awardees develop careers in the growing
area of sex differences research. Developing the workforce in this area is critical to the field
becoming fully realized. Success in this endeavor means that health and disease in women and
men will be optimally studied so that medical research benefits everyone to the highest level
possible.

Public health relevance
CEC – PROJECT NARRATIVE The CEC Core of the Colorado SCORE will focus on funding, mentoring, and training early career scientists who want to focus their research in the important and innovative area of sex differences. The CEC Core will provide team mentoring, hands-on research experience and training in the academic research skills, career development skills and methods of studying sex differences that will promote the development of a workforce in the field of sex differences research. Success in this endeavor will mean that health and disease in women and men will be optimally studied so that medical research is benefiting everyone to the highest level possible.